Pro-Survival Responses to Neurocellular Stress

PROJECT SUMMARY
Neurons, like other cells, respond to stressful stimuli by mounting a series of pro-survival
responses. When the stress is sufficiently mild and/or transient, neurons can recover and resume
apparently normal cellular and network function. This proposal builds on our recent discovery of
“actinification:” a pro-survival reorganization of the neuronal actin cytoskeleton in response to the
perturbed osmoregulation that occurs during stroke in vivo and NMDA receptor hyperactivation in
vitro in which F-actin rapidly depolymerizes from dendritic spines and assembles into long,
extremely stable filaments within the soma and dendrite. Actinification is induced by the
convergence of cell swelling and calcium influx that activates inverted formin 2 (INF2). Direct
manipulation of the level and activity of INF2 show that it positively regulates the induction of
actinification and subsequent resistance to cell death. Our central hypothesis is that INF2-
dependent actin reorganization is an essential mechanism that confers a temporary pro-survival
advantage to neurons undergoing excitatory stress by protecting the somatodendritic
compartment from acute damage while preserving synaptic circuitry. We propose to apply
biochemistry and cell biology approaches to a) identify the molecular mechanisms that underlie
INF2-dependent actinification; b) to define how actinification confers resistance to cell death and
c) to characterize actinification-associated changes in synapse functionality during stress and
recovery. These experiments will accelerate a fundamental understanding of pro-survival
responses to stress that are specifically relevant to stroke, seizure, and brain trauma, and broadly
relevant to Alzheimer’s and other chronic conditions that are exacerbated by excitotoxicity.

Public health relevance
NARRATIVE Stroke, seizure, and brain trauma cause acute injury to neurons through excitatory cell stress, yet few treatment options are available. This project investigates basic cellular and molecular mechanisms that confer a pro-survival advantage during neuronal cell stress, and will identify potential new therapeutic targets for treating CNS injuries.